KC Donnelly Externship Admin Supplement for Francisco Leniz P42ES007380 UKSRC

KC Donnelly Abstract for Francisco Leniz PD/PI: Kelly Pennell
Abstract
The challenge of providing drinkable water to the world population, and its close relation to the need of
purifying natural water from contaminants has been present throughout the history of the humankind. As
part of the Project 3 at the UKSRC, “Responsive Membranes and Advanced Materials for Sensing and
Remediation of Halo-organics”, we have been working on the development of multifunctional materials
toward the increase of separation rates, more energy efficient, and portable technologies. Per- and
polyfluoroalkyl substances (PFAS) were our case of study in our previous manuscript. Bringing together
Project 3 at the UKSRC and Project 4 from MEMCARE at Yale University, “Designing the next
generation of highly selective sorbents for water remediation”, means merging teams' efforts with a
common goal, the remediation of water for the society. Recently, Project 4 from MEMCARE has focused
on developing selective adsorbents for the separation of Arsenic in water from non-contaminant
competitors. Our knowledge on synthesis of multifunctional platform can provide intriguing opportunities
for the integration of these adsorbents. Overall, this experience will expand my understanding of
separation technologies and the transport mechanisms of solutes through these, for the application of a
broader range of contaminants in water, from organic to inorganic anions. The pore-functionalized
adsorptive nanofiltration membranes, with the integration of highly selective adsorbents, is hypothesized
to bring new high separation rates in a more compact fashion, which can benefit people and communities
by easing the portability of this technology.

Public health relevance
KC Donnelly for Francisco Leniz PD/PI: Kelly Pennell Project Description The research project I would be performing during the KC Donnelly externship would be focusing on the development of a selective and compact polymeric platform for the use in separation of arsenic and other inorganic pollutants from water. This platform is meant to be both an extension and an improved version of my previous work, that was about the synthesis of dual-functional adsorptive nanofiltration (NF) membranes as an innovative technology for the separation of per- and polyfluoroalkyl substances (PFAS) from water. This last work was performed within the Project 3 of the UKSRC. Dr. Zimmerman's group, from Project 4 from MEMCARE at Yale University, has recently studied selective platforms to separate arsenic and selenium from water, avoiding non-contaminant adsorbing competitors such as phosphate. Combining both groups' efforts for the remediation of contaminated water using selective and multifunctional separation platforms has the potential of creating a breakthrough in terms of separation technologies for the treatment of water contaminated with ionic species. Specifically, I will be learning about the separation technologies and the current challenges for separating arsenic from water, as well as learning from the technological advancements from Dr. Zimmerman's group. These last would lead me to the synthesis of a properly designed selective and compact separation platform for the removal of arsenic from water. The benefits of this platform will be further investigated, as well as the potential of this technology to be functionalized with different properties to expand its application to the removal of other ionic pollutants from water.